CSHL 2022 Glia in Health & Disease Conference

2022 Cold Spring Harbor Laboratory Conference
GLIA IN HEALTH & DISEASE
Abstract
The proposed meeting on Glia in Health & Disease will be held at Cold Spring Harbor
Laboratory from July 21 – 25, 2022. The goal of this conference is to provide an active forum for
exchange of results in the rapidly advancing fields of glial biology and neuron-glia interactions.
Glial cells comprise a diverse group of non-neuronal cells that are essential for nervous system
development, circuit function, and neurological disease. These cells perform many important
roles, such as sculpting developing circuits, regulating neurotransmitter signaling between
neurons, providing metabolic support to neurons and other glial cells, supporting the fast and
efficient propagation of action potentials, modulating vascular development and blood flow, and
regulating inflammatory cascades in disease. With the advancement of genetic tools to
specifically target glia, we are now gaining a deeper mechanistic understanding of these and
other glial cell functions in health and disease. This includes a new realization that glia actively
modulate neural circuit function, plasticity, and behavior under healthy, steady-state conditions.
We are also now appreciating how these functions go awry in disease, leading to circuit
dysfunction, chronic inflammation, and destruction of neurons and their synaptic connections.
There are also clear indications that glia may not only react to diseased neurons to propagate
disease, but they are a part of the underlying etiology. For example, many gene mutations
linked to neurodegenerative diseases, such as Alzheimer's disease and multiple sclerosis (MS),
are in genes enriched in glia. Further genetic manipulation studies are beginning to reveal how
these mutations alter glial cell function and contribute to disease. Adding to the complexity in
disease, glia can also be beneficial and promote regeneration and tissue repair by performing
functions such as providing metabolic support, engulfing debris, and forming protective glial
scars. This meeting will highlight the latest developments in glial cell biology obtained through
studies of invertebrate and vertebrate model systems, as well as human tissue and cells, using
the most up-to-date genetics, molecular biology, biochemistry, physiology, and imaging
technologies. Using the goals and format of the eight prior extremely successful meetings as a
guide, we plan to: 1) assemble an international meeting of scientists engaged in studies of glial
biology and neuron-glia interactions; 2) discuss new and exciting developments in the field by
selecting talks from openly submitted abstracts on the basis of scientific merit; 3) provide an
opportunity for junior scientists of diverse backgrounds to present their data and engage in
scientific discourse with more established investigators; and 4) promote collaborative
interactions to accelerate the pace of discovery and identify novel approaches to better
understand nervous system function and, ultimately, target glial cells to treat neurological
diseases.

Public health relevance
2022 Cold Spring Harbor Laboratory Conference GLIA IN HEALTH & DISEASE PROJECT NARRATIVE Nervous system function depends on the coordinated activity of both neurons and glial cells. New developments in molecular genetics, imaging, and “omic” studies are revealing how distinct classes of glial cells contribute to brain development, plasticity, and disease. Glial are, thus, emerging as a priority target for the development of novel therapeutics to treat diseases of the nervous system and promote repair following injury. This biennial international conference (which began in 2006) will bring together the leading experts and trainees in glial biology and provide a forum for these scientists to interact and share their latest discoveries.